RADIOLOGY CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Specific Aims: The goal of the Research Radiology Core Facility is to provide dedicated equipment and staff to ensure that research subjects receive high quality, consistent mammography, ultrasound and bone densitometric scans in a centralized location with scheduling that will assisst in subject retention. Space for this core has been identified and renovation funds requested. The Specific Aims are: 1. To equip and staff a Researc Radiology Core Facility with the ability to carry out mammography, high resolution ultrasonography, and bone densitometry. 2. To provide radiological services to research faculty and assist in the collection ad interpretation of research data.